Decentralizing Breast Biopsy Procedures for Early Cancer Diagnosis In Rwanda

PROJECTS SUMMARY/ABSTRACT
BACKGROUND: With 2.3 million new cases per year, breast cancer is among the most diagnosed cancers in
women globally and is the leading cause of cancer mortality in low-and middle-income countries (LMICs),
including Rwanda. Breast cancer outcomes in LMICs are far worse as 33-90% of women with breast cancer
present with advanced-stage disease, due to delays in diagnosis exacerbated by the absence of decentralized
biopsy services, forcing patients in rural areas to travel to tertiary centers for diagnosis. Centralization of breast
biopsy creates bottlenecks and delays treatment initiation. The feasibility of implementing decentralized breast
biopsy services at district (Level II) hospitals to facilitate early cancer treatment, save lives, and create
sustainable improvements in breast cancer care across Rwanda has not yet been demonstrated. This research
aligns with National Cancer Institute’s focus on implementation science and health systems research, cross
disciplinary capacity development in research methods for LMICs, and technology for cancer control, in
addition to Fogarty’s support for global health research, partnerships, and capacity building. CANDIDATE: This
Emerging Global Leader (K43) Award will transition the clinician researcher and faculty general surgeon at the
Center for Equity in Global Surgery, University of Global Health Equity to independence in strengthening breast
cancer care in Rwanda through rigorously researched, locally relevant interventions that increase access to
early cancer biopsy, and timely, high-quality care. He will gain additional training in advanced health services
research, qualitative research and implementation research, and clinical epidemiology with process
improvement. This K43 will support his long-term career goals by offering structured training in critical areas,
guidance from leading global experts, and applied research experience to accomplish his scientific objectives.
RESEARCH: The researcher will evaluate the capacity, determinants, and feasibility of integrating
decentralized breast biopsy services into district (Level II) hospitals across Rwanda through the following
AIMS: 1- Quantitatively evaluate the capacity and organizational readiness for decentralized breast biopsy
services at district hospitals across Rwanda; 2- qualitatively assess the facilitators and barriers to implementing
decentralized breast biopsy services at district hospitals across Rwanda; 3- To assess feasibility of
implementation of decentralized breast biopsy services at five district hospitals. Innovation: Defining optimal
means to reduce reliance on centralized systems, using innovative technology-driven training tools including
gamification, simulation, and extended reality to train, pioneering use of organizational readiness tools in the
global breast biopsy space are innovative. Few global surgeons are in the cancer implementation science
space. DELIVERABLES AND FUTURE DIRECTIONS: The researcher will publish 8 relevant manuscripts and
submit an R01 proposal to test the impact of implementing decentralized models of care across the region.

Public health relevance
NARRATIVE This project will explore how to bring breast biopsy services closer to communities by making tissue biopsy available at rural district level hospitals in Rwanda, making it easier for patients to get early cancer diagnosis and treatment. By improving access to life-saving diagnostic care, the study aims to reduce health disparities, save lives, and strengthen health systems in underserved communities. In the long term, this research could serve as a model for expanding cancer care in similar settings worldwide.